Novel Approaches to Therapy of Muscle Ion Channelopathies

We will study mouse models of two muscle diseases with abnormal electrical activity. In
myotonia congenita, hyperexcitability is caused by loss of function mutations in the muscle ClC-
1 chloride channel (an anti-excitability subthreshold current). Myotonia (muscle stiffness) is
caused by unwanted firing of action potentials. Hyperkalemic periodic paralysis (HPP) is caused
by gain of function mutations in the muscle Nav1.4 sodium channel, which increase a non-
inactivating Na current (Na persistent or NaP). Patients with HPP suffer from both myotonia and
attacks of weakness caused by depolarization of muscle by NaP, which inactivates the Na
current responsible for action potentials (Na transient current, NaT). We will determine whether
block of NaP rather than NaT is the mechanism underlying efficacy of Na channel blockers in
treating myotonia congenita. We will use a genetic, a pharmacologic and a computer model of
myotonia congenita to examine the roles of NaP and NaT in triggering hyperexcitability. We will
also determine whether selective block of NaP provides effective therapy for hyperkalemic
periodic paralysis (HPP). Na channel blockers have surprisingly been ineffective in treating HPP.
We hypothesize treatment failed because the blockers used were not selective for NaP so block
of NaT worsened weakness. If we are correct that NaP regulates excitability, it would suggest
the approach to developing new Na channel blockers needs to be fundamentally altered.
Instead of identifying drugs which block NaT, the goal would be to identify drugs which block
NaP, but do not block NaT. Development of selective blockers of NaP could improve therapy of
muscle channelopathies, cardiac arrhythmias, epilepsy and neuropathic pain.

Public health relevance
We will study mouse models of two muscle diseases with abnormal electrical activity (myotonia congenita and hyperkalemic periodic paralysis). We will determine whether blocking a small Na current in skeletal muscle can effectively treat muscle stiffness and weakness in both disorders. If we are correct, this approach could be extended to cardiac arrhythmias, epilepsy and neuropathic pain.